Non-Invasive Imaging of Neurological Glycogen Storage Disease

PROJECT SUMMARY/ABSTRACT
Lafora disease (LD) is a fatal, autosomal recessive, neurodegenerative disorder that presents as epilepsy in
late childhood or adolescence and is followed rapidly by cognitive deterioration, dementia, and death within 10
years of onset. Currently, there is no treatment and anti-seizure drugs are only beneficial in early stages. LD is
characterized by the intracellular accumulation of glycogen-like aggregates called Lafora bodies (LBs) that
occur in cells from most tissues, thus LD is also a glycogen storage disease (GSD). Although multiple labs are
defining LD cellular and behavioral disease sequela as well as developing therapies, there is currently no
biomarker to assess LD progression and/or treatment efficacy non-invasively. We recently reported a novel
approach for imaging glycogen non-invasively using the nuclear Overhauser effect (NOE) between aliphatic
and hydroxyl protons in glycogen that can be detected with standard MRI equipment. Using this glycoNOE
approach, we successfully showed that changes in liver glycogen could be measured dynamically with high
temporal and spatial resolution. Importantly, there was a linear correlation between glycoNOE contrast and
glycogen concentration.
The objective of this grant is to establish a quantitative MRI test for reporting LB load and treatment efficacy in
muscle and brain non-invasively. To achieve this, we will utilize LD mice as our model system, and we have
set the following specific aims (1a) Establish a robust glycoNOE MRI protocol for detecting LBs in skeletal
muscle, (1b) Calibrate glycoNOE MRI in muscle as a function of concentration of glycogen, (2a) Develop a
glycoNOE MRI-based quantitative test for reporting LBs in the brain, (2b) Longitudinal study of LD in mice
using glycoNOE, (3a) Utilize glycoNOE MRI to monitor LB levels in LD mice after a therapeutic intervention,
(3b) Assess the re-accumulation of LBs after treatment.
These aims will result a non-invasive method for imaging glycogen changes in the brain and muscle with high
spatial resolution. The methods developed in this proposal will be immediately translatable to standard human
MRI scanners. This technology will be applicable to all glycogen storage diseases, which affect about 1 in
15,000 and thus expand the scope beyond LD. The proposed aims are critical to enable translation of these
results into diagnosing and monitoring of treatments for LD and the broader GSD patient population.

Public health relevance
NARRATIVE There is an ongoing effort to develop therapies for glycogen storage disease (GSD) but currently there is a lack of biomarkers to assess GSD progression and/or treatment efficacy non-invasively. We propose to develop a quantitative test for reporting glycogen load in muscle and brain using standard MRI equipment. This approach will result in a non-invasive tool for imaging glycogen changes in vivo with high spatial resolution and applicable to all glycogen storage diseases.